MOLECULAR VISUALIZATION PROGRAM VMD

Current emphasis is on integration methods for molecular dynamics that can be incorporated into NAMD. The relatively high cost of fast full electrostatics is reduced in NAMD by a factor of four through the use of Verlet-I/r-RESPA/impulse multiple time stepping, in which the full electrostatics is evaluated only every 4 fs. To further increase the time step for these calculations, the mollified impulse method [60] was devised and implemented for flexible water. The variants of the method tested thus far enable an increase in the longest time step from 4 fs to 6.25 fs without introducing Langevin damping. The cause of the time step barrier at 7 fs is under investigation and possible remedies are being devised. Also begun is work on an optimal choice of the force partitioning for multiple time stepping. Observations suggest that non-linear instabilities limit the time step. A related project is making advances in understanding this phenomenon.